Mechanisms underlying caloric restriction-mediated resolution of atherosclerosis

PARENT PROJECT SUMMARY
Obesity and atherosclerosis are frequently comorbid conditions contributing to substantial morbidity and mortality
worldwide. The processes are characterized by inflammation in the adipose tissue and vasculature, respectively,
that share many pathophysiologic pathways. Although processes underlying obesity and atherosclerosis-related
inflammation are well studied, the signals that promote disease resolution and remission are largely unknown,
especially in the context of concomitant inflammation resolution. As a postdoctoral fellow, I investigated how
weight loss influences cardiovascular disease and found that caloric restriction-induced weight loss in obese
mice promotes resolution of atherosclerosis, independent of plasma cholesterol. One critical aspect of
atherosclerosis resolution with weight loss was the decrease in plaque necrotic core content, which is believed
to be the most dangerous, unstable area of plaques. Mechanistically, we found that weight loss promotes
beneficial changes to immune progenitors, as well as induces the accumulation of a new macrophage subtype
(highly expressing Fcgr4) that is unique to tissues following weight loss. The R00 will build upon these exciting
findings, and we will further determine how these two immunological aspects contribute to weight loss- induced
resolution of atherosclerosis. I propose in Aim 1 to evaluate the necessity of Fcgr4 macrophages accumulation
in the adipose tissue with weight loss for resolution of atherosclerosis. Additionally, we will examine the
transcriptome and epigenome of obese humans and mice immune progenitors following weight loss, to further
understand what facilitates their alteration and decreased inflammatory output. In Aim 2, I propose to further
investigate the function of Fcgr4 macrophages, particularly in the context of necrotic core reduction that is
associated with weight loss. These studies will identify novel molecular pathways that may be targeted for the
treatment of atherosclerosis-related inflammation in obese subjects.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is the leading cause of death worldwide and obesity is a major risk factor for the development of atherosclerosis and other metabolic diseases. We showed that weight loss induced by caloric restriction promotes resolution of atherosclerosis and here we propose to study the underlying mechanisms. The present studies will uncover novel pathways responsible for the concomitant resolution of obesity and atherosclerosis.